VIRTUAL POOLED REGISTRY (VPR) PROJECT

Coordinated by the North American Association of Cancer Registries (NAACCR) with funding from the National Cancer Institute, the Virtual Pooled Registry Cancer Linkage System provides a single location to facilitate timely access to and use of high quality cancer surveillance data for minimal risk linkage studies. Use of an automated, standard linkage methodology and streamlined application process will significantly reduce the level of effort researchers and registries must dedicate to the linkage and approval process.